Microfluidic technology for a full-page braille and graphical tactile display

PROJECT SUMMARY/ABSTRACT
The goal of this SBIR project is to deliver a multiline refreshable braille and tactile graphics display to the U.S.
market. Our envisioned product is a tablet-like device that enables new forms of touch-in, touch-out interaction
between blind people and braille and tactile graphics. Thousands of tiny tactile pins in a grid at braille spacing
will be selectively and interactively raised on a multi-touch sensing surface. Our device will play a critical role in
establishing equity in information access for blind people, particularly in education. It will reduce the reliance on
hardcopy and static, physical media that currently limit a blind student’s independence and success.
NewHaptics has developed microfluidic technology that allows a small number of electronic valves to
individually address and control the thousands of actuators and moving pins in a low-cost and highly
manufacturable product. Fluid-based circuits in a tiny soft silicone chip are employed to raise and lower bubble
actuators using a one-to-many conversion between an electronic valve and bubbles. Our product will enable
true digital interaction using the sense of touch and enhance the quality of life of blind Americans by improving
opportunities in education, and ultimately their employment success and independence.

Public health relevance
NARRATIVE This project will significantly reduce the burden of accessing information for the 1.5 million blind people in the United States by making multiline braille text and tactile graphics available in a device resembling a tablet computer. Such a display will provide increased access to braille and enable blind students to read digitized spatial content including mathematical equations, graphs, and figures with their fingers, creating parity with their sighted counterparts interested in STEM fields. Our product will improve braille literacy, opportunities in STEM fields, and ultimately the employment success and independence of blind Americans.